Regulation of mTOR signaling in the developing cerebral cortex as a point of convergence for multiple autism risk factors

PROJECT SUMMARY/ABSTRACT
Signaling through mTOR is a critical regulator of protein synthesis in the developing brain, and numerous
autism spectrum disorder (ASD) and intellectual disability (ID) risk genes have been identified that impinge on
mTOR signaling and cause altered growth and connectivity at the level of brain areas/circuits or individual cell
types. Mutations in dual-specificity tyrosine phosphorylation-regulated kinase 1a (DYRK1A) cause
microcephaly and neuronal undergrowth in a subset of individuals with ASD and ID, as well as in mouse
models. The mechanisms by which mutations in DYRK1A lead to microcephaly and ASD/ID are unknown but
are critical to identify for the development of targeted treatments. Given the observations that multiple ASD risk
genes that impact overall brain growth exhibit altered mTOR signaling and that decreased mTOR signaling in
the developing cerebral cortex has been linked with microcephaly, pyramidal neuron undergrowth and deficits
in behavior and cognition, we are testing the hypothesis that DYRK1A mutations cause microcephaly,
neuronal undergrowth and ASD-relevant behavioral deficits through dysregulated mTOR signaling.
Preliminary data collected during the previous funding period indicate that mTOR signaling is downregulated in
the developing cerebral cortex of Dyrk1a mutant mice, and that upregulation of mTOR signaling via genetic
suppression of Pten or pharmacological treatment with IGF-1 can rescue microcephaly and neuronal
undergrowth in this model. The two aims of this proposal are designed to: 1) profile the effects of cerebral
cortical Dyrk1a mutations on neuroanatomical and behavioral phenotypes relevant to the DYRK1A clinical
population and to dysregulated mTOR signaling, and 2) test the hypothesis that Dyrk1a and mTOR signaling
act in a common regulatory network to influence ASD-relevant brain growth and behavioral phenotypes.
Completion of this project will elucidate molecular and cellular mechanisms of microcephaly, neuronal
undergrowth and ASD-relevant behavioral deficits caused by mutations in DYRK1A and other ASD/ID risk
genes that impinge on the mTOR pathway and will guide the development of treatments for the DYRK1A
clinical population.

Public health relevance
PROJECT NARRATIVE Understanding how mutations in DYRK1A cause decreased neuronal growth will give us important insight into the pathobiology of ASD/ID and microcephaly and identify potential therapeutics for this condition. This proposed research will study the neurodevelopmental relationship between Dyrk1a mutations and mTOR signaling, a biological pathway known to be dysregulated in humans with autism spectrum disorder and intellectual disability. The goal of this project is to identify a mechanism by which Dyrk1a mutations cause altered brain and neuronal growth and ASD-relevant behaviors and ultimately rescue these alterations through genetic and pharmacological interventions.